Ultrasound Stimulated Chondrogenic Stem Cell Therapy for Osteoarthritis

Abstract
Osteoarthritis (OA) is the most common degenerative disease in the musculoskeletal system. While it can affect any
joint, hip, and knee, OA carries an enormous burden of pain and reduced mobility. Despite decades of research, there
are currently no clinically effective treatments that can repair damaged cartilage or halt the progression of this disease.
However, recent advances in tissue regeneration show that stem cell therapy has the potential to repair damaged
cartilage. In addition, ultrasound (US) stimulation has also shown encouraging results in treating OA symptoms. This is
because cartilage is a mechanotransductive tissue that responds anabolic to biomechanical stimuli. Therefore, we
hypothesize that the combined use of stem cells and US will have a synergistic response in treating OA. This hypothesis
will be tested in three specific aims. In the first aim, we compare the chondrogenic differentiation of two different stem
cell sources, mesenchymal and adipose, using in vitro 3D culture and US exposure time period. In the second aim, we will
implant the optimal US-enhanced chondrogenic cells from Aim 1 in human articular cartilage defects, ex vivo, and
compare pulsed to continuous ultrasound. Finally, in the third aim, we will test the optimized US-enhanced
chondrogenic hyaluronic hydrogel encapsulated cell in vivo using an OA rat model. These studies will allow us to
develop a new ultrasound-induced chondrogenic stem cell therapy that can repair cartilage tissue, regress the OA
progression, and reduce osteoarthritic pain signiﬁcantly.

Public health relevance
Narrative Osteoarthritis is a debilitating disease that affects an enormous number of people. No treatments other than arthroplasty have been developed to stop its progression, reduce pain, and increase range of motion. This proposal seeks to combine the use of hydrogel ,stem cells, and ultrasound therapy to develop a new treatment for osteoarthritis. These approaches have shown some promise alone and their combination will pave the way for a new therapy to reduce OA-associated pain and improve mobility. Importantly, these experiments have been designed to facilitate a rapid proof-of-concept to pave the way for future clinical studies.